Role of the Cell Death Machinery in a Somatic Autoinflammatory Syndrome

PROJECT SUMMARY
The autoinflammatory syndromes are a group of genetic diseases often caused by defects in innate immune
genes. In December 2020, a novel somatically acquired autoinflammatory syndrome termed VEXAS (vacuoles,
E1-ubiquitin-activating enzyme, X-linked, autoinflammatory, somatic) was reported. VEXAS is caused by
somatic mutations in the ubiquitin-activating enzyme UBA1, most of which occur at an internal translation start
site (Met41). As UBA1 is X-linked, VEXAS primarily affects males who mosaically harbor UBA1 mutations in
hematopoietic stem and progenitor cells and their myeloid, but not lymphoid, progeny. These patients develop a
constellation of clinical sequelae, including hematologic abnormalities, recurrent fevers, arthritis, and skin and
lung inflammation. As a result, patients may require allogeneic bone marrow transplantation and suffer significant
morbidity and mortality. Currently, our molecular and cellular understanding of VEXAS pathogenesis is limited
by a lack of experimental model systems. To address this, we deploy an adenine base-editing system to recreate
one of the most common VEXAS mutations in mouse or human macrophages and hematopoietic
stem/progenitor cells (HSPCs). Using this system, we have found that mouse and human macrophages with a
VEXAS-associated UBA 1 mutation undergo aberrant cell death during responses to tumor necrosis factor (TNF)
or lipopolysaccharide (LPS, a toll-like receptor (TLR)4 ligand), and that VEXAS HSPCs spontaneously
differentiate into myeloid cells. These cellular phenotypes correlate with key aspects of VEXAS pathogenesis in
humans (i.e. autoinflammation and myeloid expansion) and thereby offer a platform for deciphering disease-
driving mechanisms. In Aim 1, we will use this newly developed cell system to determine the mechanisms of
TNF- and TLR4-driven cell death in macrophages carrying a VEXAS-associated UBA1 mutation. In Aim 2, we
will investigate the role of ubiquitin-dependent signaling in this cell death phenotype. In Aim 3, we will elucidate
mechanisms underlying the spontaneous myeloid differentiation of HSPCs with a VEXAS-associated UBA1
mutation. If successful, our proposal promises to yield fundamental insights into a devastating autoinflammatory
disease with potential implications for understanding the interrelationships between clonal hematopoiesis and
inflammation.

Public health relevance
PROJECT NARRATIVE Multiple clonal diseases of the bone marrow have been associated with inflammation. VEXAS is a newly described syndrome in which a somatic mutation causes both clonal expansion of a hematopoietic progenitor cell and severe autoinflammation by unknown mechanisms. This proposal examines the role of aberrant inflammation-induced cell death as a mediator of pathogenesis of VEXAS, with the potential for shedding light on disease etiology and nominating novel therapeutic strategies.